Clinical trial emulation to assess drug safety in pregnant patients

ABSTRACT Pregnant people are a vulnerable population: healthcare professionals must exercise caution in prescribing many common pharmaceuticals to expectant patients, given potential risk of injury to a developing fetus. Arguably, teratogenicity is the most serious manifestation of fetal toxicity, as teratogens lead to fetal malformation and are implicated in physical and mental disabilities throughout the life course of an affected child. Consideration of teratogenicity, however, is a largely nonsystematic process. While regulatory agencies like the United States Food and Drug Administration have established discrete teratogenicity scores for evaluating drug safety, these classification criteria provide little concrete distinction among score classes, making it difficult for pharmaceutical scientists to systematically determine the teratogenic potential of a drug. This effect ripples to the bedside, as providers lack robust data on most drugs to inform their judgements of safety, efficacy, and risk in recommending therapies to expectant patients. Consequently, treatment of many diseases during pregnancy remains understudied and uncertain, for fear of causing harm. To address these shortcomings and improve quality of care for pregnant patients and their unborn children, we propose the development of a holistic, generalizable framework for the identification of teratogenic drug exposures via a new paradigm of clinical pharmacovigilance. Therefore, given our inability to evaluate drug safety in pregnant patients in real time, the objective of our investigation is to develop an observational platform to uncover new drug safety information through strategic, associative analysis of medication history within the electronic health record (EHR) of a pregnant patient and developmental diseases within the EHRs of their neonates. This approach will harness 48,434 linked maternal and neonatal EHRs within the Research Derivative, a databank of identified EHRs at Vanderbilt University Medical Center, across which we plan to apply and appropriately validate a medication-wide association study to uncover new, data-driven associations between maternal medication exposures and teratogenic health outcomes. To date, we have employed this technique to discover 129 associations between maternal drug exposure and neurodevelopmental diseases from existing primary care data, which recapitulate teratogens well-known to clinical practice that also serve as positive controls for our model. Now, we hope to expand our platform to encompass more advanced techniques of clinical trial emulation; if successful, we anticipate that discovering new toxicants through retrospective data modeling will greatly enhance our goal of systematically clarifying cases of suspect drug safety in pregnancy. In the long run, we hope this approach will allow clinicians to embrace a more accurate knowledge base in their evaluation of the risks and benefits in prescribing drugs with unclear teratogenic risks to their pregnant patients.

Public health relevance
PROJECT NARRATIVE From the perspective of regulatory agencies for public health and safety, it is unethical to perform clinical trials on pregnant people to assess drug safety and efficacy for the treatment of diseases of pregnancy; paradoxically, while this policy recognizes the vulnerability of an expectant mother and her unborn child, it has created a public health emergency for millions of pregnant patients, as clinicians lack robust data on treatments for these conditions and still do not know whether many common drugs are safe to prescribe to their pregnant patients. To address these problems, this project aims to harness the burgeoning science of machine learning to create a surrogate for randomized, controlled drug trials in pregnant populations, via the development of a “target trial” platform to discover new drug safety and efficacy insights from medication and disease data in linked maternal and neonatal electronic health records that were originally collected during routine medical care. Upon completion of this project, pharmaceutical scientists may employ the resulting target trial framework to clarify drug safety concerns for pregnant patients, and clinicians may benefit more definitive data in their choice of safe and effective medications for expectant mothers.